Novel Enediyne-Based Antibody-Drug Conjugates for Cancers

PROJECT SUMMARY
The 15 FDA-approved antibody-drug conjugates (ADCs) and nearly all ADCs in clinical trials are prepared by
random drug conjugation, affording a heterogeneous ADC mixture that compromises both efficacy and safety.
Site-specific conjugation is a major recent improvement to ADC development, yielding homogeneous ADCs
with improved therapeutic index. Drugs currently used as ADC payloads generally fall into three categories –
tubulin binders, DNA-targeting, and topoisomerase inhibitors. The ADC field is in critical need of diversifying
payloads to address challenges encountered with the current ADCs. We propose in this application to
develop tiancimycin (TNM)- and lactimidomycin (LTM)-based and site-specifically conjugated ADCs, targeting
CD79b and ROR1, as next generation therapies for hematologic malignancies. Our hypotheses are: (i) TNMs
and LTMs are outstanding ADC payloads owing to their exquisite potency and modes of action (MOAs), (ii)
TNM and LTM biosynthesis and fermentation optimization enable the production of designer payload
candidates to develop the linker chemistry, (iii) the dual variable domain (DVD) platform enables site-specific
conjugation of TNMs and LTMs to the orthogonally reactive Lys or arginine (Arg) residue of DVDs to generate
homogeneous ADCs, and (iv) complementary targeting of CD79b and ROR1 helps evaluate the novel TNM-,
LTM-, or TNM-LTM dual drug-based ADCs and develop them into next-generation ADCs for hematologic
malignances that currently lack effective treatments. The specific aims for this renewal project period are:
development and optimization of linker and conjugation chemistry and preparation (i) of TNM- and LTM-based
and CD79b- and ROR1-targeting ADCs by site-specific conjugation to the reactive Lys residue of DVDs and (ii)
of TNM-LTM dual drug-based and CD79b- and ROR1-targeting ADCs by site-specific conjugation to the
orthogonally active Lys and Arg residues of DVDs, and evaluation of selectivity and potency (iii) of TNM-, LTM-
, and TNM-LTM dual drug-based and CD79b- and ROR1-targeting ADCs against selected CD79b+ and/or
ROR1+ cell lines and primary patient samples and (iv) of LTM- and TNM-LTM dual drug-based and CD79b-
and ROR1-targeting ADCs against selected CD79b+ and/or ROR1+ cell lines or primary patient samples, in
combination with drugs known to induce resistance, first in vitro and subsequently in vivo in mouse models.
The outcomes of this application include: (i) fundamental contributions to ADCs and (ii) a panel of TNM-, LTM-
, and TNM-LTM dual drug-based and CD79b- and ROR1-targeting ADCs as next-generation therapies for
hematologic malignances. The long-term goal of our research is to discover novel microbial natural products
and harness their exquisite cytotoxicity and MOAs as ADC payloads for anticancer drug discovery.

Public health relevance
PROJECT NARRATIVE New cases of hematologic malignancies are expected to account for 9.4% of the estimated 1,958,310 new cancer cases that will be diagnosed in the US in 2023 and 9.4% of the deaths from cancer in 2023 based on the estimated total of 609,820 cancer deaths in US. This project aims at developing novel DNA damaging and protein synthesis inhibiting drug-based site-specific antibody-drug conjugates that target CD79b and ROR1 as next generation therapies for hematologic malignancies that currently lack effective treatments. The long-term goal of our research is to discover novel microbial natural products and harness their exquisite cytotoxicity and modes of action for anticancer drug discovery.